Long-term health and socioeconomic impact of interventions targeting low-density malaria infection (LMI) among children in Tanzaniav

Project Summary/Abstract
As malaria transmission declines, an increasing proportion of infections persist in the body at low levels.
Low-density malaria infection (LMI) are often chronic and represent a high proportion of infections among
children in the community and children presenting with fever, but they have been largely ignored because
standard point-of-care diagnostics have limited sensitivity to detect them, and they are considered incidental or
beneficial in that they may provide protective immunity again future malaria illness. However, much of this data
comes for high transmission settings and results are mixed. Also data from lower transmission settings
suggests negative health consequences. There is a growing body evidence to suggest that LMI are associated
with recurrent malaria, chronic anemia, poor growth, co-infection with invasive bacterial disease, and cognitive
impairment. Data from trials of intermittent preventative therapy (IPT) and mass drug administration (MDA)
also suggest benefits of treating LMI. However, these presumptive treatment strategies can also promote drug
resistance and are not practical in low transmission settings. More sensitive detection methods including
molecular approaches are increasingly available, but evidence of their effectiveness to reduce disease burden
is lacking. To inform policy and practice, there is an urgent need for evidence on the impact and safety of
detecting and treating LMI in children. The objective of the proposed project is to determine the long-term
health and socioeconomic effects of detecting and treating LMI in children. We hypothesize that compared to a
standard of care where malaria detection is passive and based on standard diagnostics (PCD), detecting and
treating LMI through use molecular detection methods in active case detection (ACDm) and passive case
detection (PCDm) in children will improve all-cause morbidity and have cognitive and socioeconomic benefits.
To test this hypothesis, we propose to conduct an open-label randomized controlled trial in children 6 months
to 10 years of age at an established trial site in Bagamoyo, Tanzania, where transmission is low and we have
found that a high proportion of infections are low-density. The effects of treating Plasmodium falciparum LMI
through active or passive case detection may differ. As such, we will study these as separate interventions and
compare each to the standard of care. A population representative sample of 600 children total will be recruited
(n=200 per arm, inclusive of 15% loss to follow-up) enabling at least 85% power (two-sided a=0.05) to detect a
20% effect size for each of the interventions compared to control. Children will be randomized into one of three
study arms: 1) standard of care PCD (Control) whereby children presenting with fever will receive artemether
lumefantrine (AL) based on positive rapid diagnostic test (RDT) result, 2) ACDm (Arm 2) whereby children will
receive testing for malaria (using RDT and qPCR) three times annually, with AL administered for RDT or
qPCR-positivity, and 3) PCDm (Arm 3), in which children, when they have fever, will receive testing for malaria
(using RDT and qPCR) with AL administered for RDT or qPCR-positivity. Standard PCD will be conducted in
Arm 2 and no ACD will be conducted in Arm 3. To capture subacute or chronic effects, follow-up will occur over
2 years. Specific aims are: (1) To assess the impact of standard PCD plus ACDm vs standard PCD
alone on long-term child health. We hypothesize that adding ACDm will lower incidence of all-cause sick
visits. Secondary outcomes include anemia, growth, safety, malaria, antibiotic use, clinical symptoms, fever
episodes, clinical failure after fever episodes, immune responses, cognition, and socioeconomic effects. (2) To
assess the impact of PCDm vs standard PCD on long-term child health. We hypothesize that PCDm vs
standard PCD will lower incidence of all-cause sick visits. Secondary outcomes are as described in Aim 1. (3)
To evaluate the cost-effectiveness of ACDm and PCDm. To inform potential scalability of the interventions,
we will use socioeconomic cost data from Aims 1 and 2 to compare each intervention to control and calculate
outcomes including: cost per sick visit averted, per disability adjusted life years (DALYs), and per economic
dollar saved. Our approach to address the challenge of LMI from the perspective of all-cause morbidity and
socioeconomic effects is innovative as the status quo has been to consider them for their relevance to malaria-
specific outcomes and transmission; we will also utilize innovative new tools to assess cognitive evaluation and
long-term socioeconomic impact. The significance of our study lies in the increasing worldwide relevance of
LMI and its associated morbidity for children; the importance of child health for global health, society, and the
economy; and the potential for this first trial of its kind to lead to policy and practice changes.

Public health relevance
Project Narrative The proposed project is relevant to public health because evidence on the health and socioeconomic impact, safety, and cost-effectiveness of detecting and treating low-density malaria infections in children has high potential to inform malaria policy and practice and decrease the global burden of disease due to malaria. The project is relevant to NIAID’s mission to conduct applied research to understand, treat, and prevent infectious diseases.